MA Childhood Obesity Research

DESCRIPTION (provided by applicant): Project abstract The proposed Mass in Motion: Community-Clinical Partnerships to Reduce Childhood Obesity will use the Obesity Chronic Care Model to implement and evaluate a comprehensive, systematic intervention to reduce childhood obesity among underserved children. The Massachusetts Department of Public Health (MDPH), in partnership with the Department of Population Medicine at Harvard Medical School, the Harvard School of Public Health, and the National Initiative for Children's Healthcare Quality, seeks to build on promising community-level experience and related clinical obesity prevention work in communities through the statewide Mass in Motion wellness initiative to develop an intervention in two cities, Fitchburg and New Bedford, that could be replicated throughout the state. The study proposes an integrated multi-sector and multi-level approach. It incorporates evidence-based interventions in primary health care (High Five for Kids), child care (I Am Moving, I am Learning; NAP SACC) and schools/after-school programs (Food & Fun, Eat Well and Keep Moving, and Planet Health), as well as policy change and a community-wide social marketing campaign to prevent or reduce obesity among predominantly low-income 2-12-year- old children. Using a combination of pre- post time series and quasi-experimental designs, we will examine the effectiveness of our intervention on individual-level lifestyle behaviors, change in body mass index (BMI), satisfaction with health care services, and quality of life. The Specific Aims are: (1) In intervention v. comparison communities, examine the extent to which a multi-level, multi-sector intervention for children, based in pediatric primary care, early educatin and child care programs, elementary and middle schools, after school programs, and a community-wide social marketing campaign results in improvements in obesogenic behaviors. (2) In intervention v. comparison communities, achieve smaller age associated increases in BMI. (3) In health centers in the intervention communities, demonstrate increases in: BMI screening and counseling on the 5 targeted obesity-related behaviors for all children ages 2-12 years; Coordinated care by a multi-disciplinary clinical team and community health workers for children with an age- and sex-specific BMI e 85th percentile; Parental satisfaction with services and child obesity-related quality of life. (4) Collect data on the costs of the intervention activiies in preparation for cost-effectiveness analyses. (5) Develop a detailed implementation and dissemination guide for MDPH to use to support adoption in other communities across the state.

Public health relevance
Project Narrative The Massachusetts Department of Public Health has made the reduction of childhood obesity a priority, especially among racial/ethnic minority and low income populations. The proposed demonstration study will use the Obesity Chronic Care Model to implement and evaluate a comprehensive, multi-level, multi-sector intervention to reduce childhood obesity among low- income children in 2 communities of MA. __SpecificAimsTextDelimiter__ 1. Specific Aims Childhood obesity is highly prevalent, is associated with both short- and long-term adverse outcomes, disproportionately affects racial/ethnic minority and low-income children, and represents a major threat to public health. Among the most promising approaches for its prevention and management are multi-level, multi- sector strategies that support change at the individual, institutional and community levels. In 2009, recognizing the importance of community-wide mobilization to address obesity and its multiple adverse outcomes, the Massachusetts Department of Public Health (MDPH) launched a multifaceted "Mass in Motion" initiative that included policy, regulatory, and public health education components, as well as Municipal Leadership Grants. These grants, supported by both public and private funding, engage multi-sector coalitions in 14 cities in policy, environmental, and systems change to promote healthy eating and active living in their communities. These coalitions have conducted assessments and built a sound infrastructure for the more intensive intervention proposed in this project. The MDPH, in partnership with the Department of Population Medicine at Harvard Medical School, the Harvard School of Public Health, and the National Initiative for Children's Healthcare Quality, now seeks to build on this promising community-level experience and related clinical obesity prevention work to develop an integrated intervention in two of the Mass in Motion cities, Fitchburg and New Bedford, MA, that could be replicated throughout the state. The overall goal of the proposed Mass in Motion: Community-Clinical Partnerships to Reduce Childhood Obesity is to use the Obesity Chronic Care Model to implement and evaluate a comprehensive, systematic intervention to reduce childhood obesity among underserved children. Through an integrated multi- sector and multi-level approach, we will incorporate evidence-based interventions in primary health care (High Five for Kids), child care (I Am Moving, I am Learning; Nutrition and Physical Activity Self-Assessment for Child Care) and schools/after-school programs (Food & Fun, Eat Well, Keep Moving, and Planet Health), as well as policy change and a community-wide social marketing campaign to prevent or reduce obesity among predominantly low-income 2-12-year-old children. In Fitchburg and New Bedford, using a combination of pre- post time series and quasi-experimental designs, we will examine the effectiveness of our intervention on individual-level lifestyle behaviors, change in body mass index (BMI), satisfaction with health care services, and quality of life. The Specific Aims are: 1. In intervention v. comparison communities, to examine the extent to which a multi-level, multi-sector intervention for children ages 2 to 12 years, based in pediatric primary care, early education and child care programs, elementary and middle schools, after school programs, and a community-wide social marketing campaign results in improvements in 5 obesogenic behaviors: a. Decreases in screen time and television sets in bedrooms; b. Decreases in consumption of sugar-sweetened beverages; c. Increases in moderate and vigorous physical activity; d. Increases in sleep duration and improvement in sleep quality; e. Replacement of calorically-dense foods with fruits and vegetables. 2. In intervention v. comparison communities, to achieve smaller age associated increases in BMI, measured by surveillance data from community health center electronic medical records and from routine screening in schools and in Women, Infants, and Children (WIC) programs. 3. In community health centers in the intervention communities, to demonstrate increases in the following primary care activities and related outcomes: a. BMI screening for all children ages 2-12 years; b. Counseling for all children ages 2-12 years on the 5 targeted obesity-related behaviors; c. Coordinated care by a multi-disciplinary clinical team and community health workers for children with an age- and sex-specific BMI e 85th percentile; d. Parental satisfaction with health care services and child obesity-related quality of life. 4. To collect data on the costs of the intervention activities in preparation for cost-effectiveness analyses. 5. To develop a detailed implementation and dissemination guide for MDPH to use to support adoption in other communities across the state. To achieve these aims we have assembled a multi-disciplinary research team with extensive expertise in translation of evidence into effective community level policies and programs, experience working with multi- sector coalitions (including in the two target communities), obesity prevention, clinician and family behavior change, statistical methodology including quasi-experimental and time series designs, and cost-effectiveness analysis. If successful, this project will provide new and sustainable approaches for implementing large-scale interventions to prevent childhood obesity among the populations in the U.S. who need it most.